Uncovering Synthetic Potential of Distonic Radical Cations

Distonic radical cations, which possess a spatially separated radical moiety and a cation moiety, have great synthetic potential because they can enable difunctionalization at the two distinct sites by orthogonally adding a nucleophile to the cation moiety and intercepting the radical moiety with a radical acceptor. However, capturing the bimodal reactivity of distonic radical cations remains elusive because of the limitations in access to precursors, suitable producing conditions, and understanding of their reactivities to gain orthogonal control of the two reactive moieties. We develop the ring opening of cyclopropyl- and cyclobutyl-amines as a general reaction platform to produce distonic radical cations but encounter many challenges to utilize their bimodal reactivity. Our central hypothesis of the difficulty is that because the ring opening is reversible, how to perturb the reversibility effectively will be critical to harness the bimodal reactivity. We identify two strategies to affect the reversibility: the use of a nucleophile and resonance stabilization of the cation moiety in distonic radical cations. Two specific aims are developed based on these two strategies: 1) difunctionalization of distonic radical cations of cyclopropylanilines and cyclobutylanilines; 2) functionalization of distonic radical cations of spirocyclic N,N aminals or N, O acetals. If this bimodal reactivity can be successfully harnessed to enable the difunctionalization of distonic radical cations, such reactions could represent a new way for synthetic chemists to utilize cycloalkylamines as synthetic building blocks and could provide a guiding principle to discover more useful ways to employ these distonic radical cations accessed beyond the ring opening processes. These transformations fit into an emerging theme in organic synthesis: diversify carbon backbones via deconstructive functionalization of carbo- or hetero-cycles. Cleavage of a strong bond such as carbon-carbon bonds is often employed in this process to enable the functionalization of a remote and unactivated carbon.

Public health relevance
The proposed research focuses on developing new reactions by capturing the bimodal reactivity of distonic radical cations derived from cycloalklyamines. These reactions can rapidly generate many new small-molecule nitrogen-containing scaffolds with potential biological activities. These products will be sent to a collaborator for biochemical and cellular assays to identify the active compounds and their targets.